External Innovative Network Core

Project Summary
External Innovative Network Core (Core C)
The overarching aim of Core C is to strengthen national and international collaboration on
research on the demography of aging by bringing together interdisciplinary groups of researchers
around targeted themes. To achieve this aim, we will organize three continuing and one new
external network: (1) TRENDS in Old-Age Disability and Dementia, which will formally expand its
focus to include dementia trends; (2) HRS Sister Studies, which will continue to provide technical
assistance to emerging and continuing HRS family studies abroad including guidance on the
addition of genetic data; (3) Longitudinal Studies of Aging in the U.S., which will focus on emerging
survey methodological and measurement issues that cross-cut NIA-funded panel studies; and (4)
a new network on the Demography of Family Caregiving, which will emphasize how changes in
fundamental demographic processes are influencing various facets of family caregiving for older
adults. The external networks aim to share and provide technical assistance on new ways to
design, collect, and distribute survey data on the demography of aging in the US and
internationally (networks 2 and 3); and to promote new research findings on substantive topics of
high priority to the demography of aging (networks 1 and 4). These aims will be achieved through
face-to-face meetings of network members, pilot projects (through Core B), and collaborations on
special issues of journals.